Human iPSC-Derived Chimeric Antigen Receptor Macrophages to Modulate Inflammation and Combat Tau-Induced Pathology

ABSTRACT
Neurodegenerative diseases like Alzheimer's and related dementias (ADRD) manifest with chronic inflammation
and tau pathology. Passive immunotherapies have shown some success in clinical trials, but significant disease
improvement has not been achieved to date. The rapid advancement and clinical application of immune cell
based therapies in oncology has opened the door to developing innovative new cell therapies to treat
neurodegeneration. Monocytes and derivative macrophages (MΦ) engineered with chimeric antigen receptors
(CAR-MΦ) have emerged as a promising candidate for allogeneic cell-based cancer immunotherapy. MΦ are
unique from other immune cells in their capacity for tumor and tissue infiltration, and ability to phagocytosis
extracellular entities including proteins, pathogens, and whole cells. The use of primary MΦ derived from patient
blood is challenging as these cells cannot be engineered and expanded ex vivo like T or NK cells, making
complex genetic engineering maneuvers nearly impossible. We recently developed an optimized process for
production of CAR MΦ from human induced pluripotent stem cells (iPSC). Human iPSC are amenable to
complex genome engineering, and we have established a scalable process for production of genetically
engineered MΦ (iMΦ) for oncology applications. Here we propose redirecting our platform toward treatment of
Alzheimer's disease (AD). Specifically, we will evaluate a curated list of novel iMΦ-specific CAR designs for
targeting the pathogenic Tau protein and evaluate their function using a battery of biochemical and in vitro
assays. Additionally, as inflammation is a key contributor to AD pathology and also a potential risk associated
with transfer of immune cells to the central nervous system, we will pursue a two-pronged approach to address
these challenges. First, we will utilize multiplex base editing in iPSC to deactivate key inflammatory genes in
derivative iMΦ, thus rendering them inert in their ability to instigate counterproductive inflammation. Second, we
will incorporate a CAR activation-responsive genetic element in our vector that allows for selective production
and secretion of our recently published high potency and high selectivity TNFR1 antagonist, thus achieving an
additional layer of inflammatory control specifically at the sites of Tau mediated inflammation. The collective
result will be a novel, scalable, allogeneic cell platform capable of addressing both Tau mediated pathology and
associated inflammation.

Public health relevance
PUBLIC HEALTH RELEVANCE Neurodegeneration in Alzheimer's disease stems from a complex combination of misfolded proteins and associated inflammation, with minimal therapeutic progress beyond slowing inevitable disease progression. Immune cells have been repurposed as highly effective therapeutics for cancer and autoimmunity through genetic engineering, but their application for treatment of neurodegenerative disorders is largely unexplored. Here, we will implement genetic and cellular engineering to produce macrophages capable of engulfing pathogenic protein and simultaneously disrupting inflammatory cascades at the site of disease pathology.